Effect of intensity and health coaches on the translation of DPP to worksites

DESCRIPTION (provided by applicant): This project proposes to test adaptations of the Diabetes Prevention Program (DPP) designed to increase the likelihood of widespread use in workplace settings. DPP, which has been proven efficacious in clinical trials, is a six month weight management program designed to reduce caloric intake and increase caloric expenditure. As a clinic- based intervention, the original DPP intervention was tested on a high risk (pre-diabetic) target group using frequent one-on-one contact to achieve change, a model that is not generalizable to a broader population or non-clinical settings. In this study, we will determine a) if a moderate intensity adaptation of DPP can be efficacious, b) the comparative effectiveness of two intervention modalities - telephone and group, and c) the incremental cost-effectiveness of the interventions. The participating sites are two city/county governments with over 4500 employees. Participants will be randomly assigned to one of three intervention conditions: telephonic coaching and manual, group coaching and manual, and manual alone. The intervention manual that underlies all three interventions is the same as DPP. The primary outcome measure is BMI with secondary outcomes of healthy eating behaviors and physical activity. An incremental cost-effectiveness analysis will be conducted comparing each intervention to one another. Data will be collected at baseline, posttest (six months), and follow up (12 months). The hypotheses will be tested using a growth modeling approach examining changes over time. This will enable us to maximize the translation of DPP across worksite populations by using approaches which are realistic for most work organizations.

Public health relevance
The existence of high quality research findings does not in itself assure good practice. In order to effectively translate research to practice, we must understand which intervention components are most effective for implementing an evidence-based intervention. These components must be adapted to the context and culture of the setting and target population to maximize the effects of intervention. This project translates a clinically efficacious program (Diabetes Prevention Program) to a broader public health population, testing adaptations that will foster wide spread use in worksite settings. This will enable public health professionals to maximize the impact of an efficacious program, reaching a much larger population than possible in clinical settings.